Characterizing Persistent Subclinical Neurobehavioral Effects of COVID-19 in a Diverse Urban Population

PROJECT SUMMARY/ABSTRACT
Excess cognitive dysfunction has been identified in older adult survivors of COVID-19, compared to other
respiratory infections. SARS-CoV-2 may thus adversely impact the brain beyond what the cases of acute stroke,
etc. suggest. Unrecognized brain effects of SARS-CoV-2 infection may impact current brain functioning and
presage future neurodegeneration and overt neurologic dysfunction. However, absent known baseline
functioning, detection of subclinical effects will be confounded by normal variation between cases and controls.
We will therefore leverage detailed pre-pandemic neurocognitive and imaging assessments to characterize
subclinical effects on brain structure and function among a large cohort of younger patients who experienced
mild or asymptomatic SARS-CoV-2 infection. We will identify 3 groups utilizing detailed serologic analysis and
novel highly specific SARS-CoV-2 T-cell assays to allow confirmation of prior SARS-CoV-2 infection, even in the
setting of COVID-19 vaccination: (1) M ild COVID-19: 35 patients with laboratory confirmed COVID-19 who were
NOT hospitalized; (2) Asymptomatic: 35 with laboratory evidence of SARS-CoV-2 infection, but no history of
COVID-19 symptoms; and (3) Controls: 70 matched individuals without laboratory or clinical evidence of prior
SARS-CoV-2 infection. All participants were healthy prior to COVID-19, with no comorbid risk factors or brain
imaging abnormality and normal neurocognitive performance. Against this robust quantitative baseline, we will
assess change due to SARS-CoV-2 infection by repeating a suite of neurological assessments, including brain
imaging and assessments of neurocognitive function, mood, anxiety, stress and social isolation due to the
pandemic. In addition to their pre-pandemic baseline, we will assess participants (1) at entry into this proposed
study, (2) 6 months after entry, (3) 18 months after entry and (3) three years after entry, to address the following:
Aim 1 Brain Tissue Effects: Characterize change of macro/microstructure and functional connectivity frompre-
pandemic, among SARS-CoV-2 infected patients and non-infected controls, over three years.
Aim 2 Functional Effects: Assess change in neurocognitive function from pre-pandemic, among SARS-CoV-2
patients, and in non-infected controls, over three years, while accounting for mood, stress and social isolation.
Aim 3 Individual Risk Factors [Exploratory]:Explore whether individual characteristics, such as sex, BMI, SES
and race/ethnicity, modify the associations of SARS-CoV-2 infection with MRI and neurocognitive changes.
Confirming neurological morbidity in mild SARS-CoV-2 will have key implications for screening, care and follow-
up for brain dysfunction among those at risk. Theseproblems would otherwise go unrecognized, despite potential
for long-term, yet-unrecognized morbidity. Our existing sample of previously healthy, young, ethnically diverse
women and men from a high prevalence and high morbidity region, well-characterized prior to the COVID-19
pandemic, uniquely positions us to characterize subclinical brain injury and dysfunction due to SARS-CoV-2.

Public health relevance
PROJECT NARRATIVE – PUBLIC HEALTH RELEVANCE Severe neurologic complications (e.g., stroke) of COVID-19, may represent the tip of an iceberg, signaling unrecognized changes in brain structure and function among the more than 90% of patients who experienced only mild COVID-19 or asymptomatic infection with SARS-CoV-2. Unrecognized brain effects of SARS CoV-2 infection may impact daily functioning and be harbingers of future neurodegeneration and overt neurologic dysfunction. Here we will define neurological complications related to mild SARS CoV-2 infection, using sophisticated neuroimaging, neuropsychiatric examinations and detailed testing of neurocognitive functions, and will characterize their nature and scope as the first necessary steps toward addressing the problem.